Scripps Center for Oceans and Human Health: advancing the science of marine contaminants and seafood security

The overarching goal of the proposed Scripps Center for Oceans and Human Health (SCOHH) is
to advance the science and community engagement surrounding seafood pollutants in the United
States. The project brings together a multidisciplinary team of biomedical and oceanographic
researchers with broad expertise in fish ecology, microbiology, marine chemistry, technology
development, bioaccumulation, genomics, toxicology, and public health. This team will study and
track the distribution of essential micronutrients and harmful contaminants in marine food webs to
the three billion people who consume seafood globally, the roles that the marine microbiome play
in their production and transport, and the developmental toxicity of seafood pollutants and their
interactions with human drug transporters. The Center’s scientific goals and focus are guided by
the needs of society, established through bidirectional community engagement led by a proven
community engagement team. The proposed research program of SCOHH spans four main
areas which address the objectives of the NIEHS and NSF sponsored COHH4 program RFA:
1. Assessing seafood composition to advance dietary health in the U.S.
2. The marine microbiome as a source for the synthesis, transformation, and distribution of
seafood contaminants.
3. Mechanisms of bioaccumulation and developmental toxicity of seafood pollutants.
4. Seafood risks and benefits – Science, literacy, and engagement.
We expect the overall outcome of SCOHH to better inform policies, consumption guidelines, and
individual decisions to lower risk and enhance greater benefits associated with seafood
consumption by bridging science discovery, environmental health literacy, and community
engagement.

Public health relevance
The goal of the Scripps Center for Oceans and Human Health (SCOHH) is to advance the science of marine contaminants and seafood security. This multidisciplinary project involving ocean and human health scientists will examine the sources, fates, and toxicology of anthropogenic and natural chemicals in the ocean, and to probe their environmental distribution and movement through the seafood chain. Importantly, SCOHH will bridge science discovery, environmental health literacy, and community engagement to build capacity for public health risk prevention while highlighting the health benefits of consuming fish.